GCRC - CAP- BENEFICIAL EFFECTS OF SINUS RHYTHM ON HEMODYNAMIC PARAMETERS

One hundred fifty patients have been screened. Three patients were enrolled. Three other Centers are about to come on-line in an effort to expand recruitment.